Pilot and Feasibility Program

PROJECT SUMMARY – Pilot and Feasibility Program
The Pilot and Feasibility (P&F) grant program at the Chicago Center for Diabetes Translation Research (CCDTR)
supports new areas of inquiry in diabetes translation research, with a special focus on improving the care and
outcomes of vulnerable populations. The main aim of P&F program is to provide funding for investigators to
explore novel hypotheses and to obtain preliminary data in order to secure long-term support from conventional
funding mechanisms. Funding from the P&F program has supported new investigators who are seeking to
become fully independent scientists in diabetes translation research and established investigators who are
seeking to initiate diabetes-related research. Since 2011, the CCDTR P&F has received 68 applications and has
awarded 41 grants, leading to 52 abstract presentations, 55 publications, and funding of 29 grants from NIDDK,
NHBLI, AHRQ, and others. Grantees have received $25 million in subsequent awards with a return on investment
of $28 for every $1 invested. The P&F program has made a difference for many investigators and has help
establish a more diverse and collaborative network of researchers while launching the careers of several
investigators in the fields of diabetes translational research. Grants have gone to 31 (76%) women, 23 (56%)
investigators who identify as racial/ethnic minorities, and 19 (46%) women of color across eight institutions and
12 departments. The areas of study have included sleep interventions, care of patients with pre-end-stage kidney
disease, mobile phone interventions on sedentary behavior, and human centered design approaches. Looking
forward, we will amplify our reach through a novel partnership with Northwestern University (NU). This
partnership will further catalyze the work that UC and NU have been conducting by providing broader reach
across disciplines, institutions, and geography. Additionally, the P&F program will be furthered strengthened by
expanding our scope by encouraging applications from grantees who: (1) are testing novel interventions in health
equity, dissemination, and implementation; (2) bring unique perspective to diabetes research through
nontraditional fields of expertise (e.g. engineering, design, environmental science); and (3) identify as URM
and/or engage with stakeholders/community organizations that are URM serving and/or led. Acknowledging the
importance of the P&F program, the Deans of the Biological Sciences Division at UC and Feinberg School of
Medicine at NU will support the P&F program by providing $100K total in matching funds per year. With $150K
funds per year, we will grant up to five grants of $25k per year and up to five “mini” grants of $5K to improve
engagement and dissemination efforts. The success of our P&F program to date is a reflection of the
interdisciplinary nature of our center and the strong research base it provides. Through a renewal of the CCDTR
and collaboration with NU, the P&F program will be able to continue to provide necessary funding support to a
new generation of innovative and diverse diabetes translation researchers and increase their chances of
securing long-term funding in the future.